Activity-based Sensor Peptides for Direct, High-throughput, and Kinetic Quantitation of Oncogenic Protein Kinases in Unfractionated Cell and Tissue Samples

PROJECT SUMMARY 30 lines
Protein kinases catalyze selective and timely protein phosphorylation and are essential for the normal
function of all cells. Unregulated kinase activity is directly associated with hundreds of human diseases,
including cancer; an estimated 30% of all new drug development focuses on this target class. Unfortunately,
although protein kinases are validated drug targets and kinase inhibitors represent promising treatments for
diseases, the challenge for small molecule drug discovery and development is that the current kinase assay
methods are inefficient and commonly only work under limited conditions. A significant barrier to progress
centers on the tools applied to assay protein kinases throughout the drug discovery pipeline. Although many
assay platforms exist, severe limitations in the various sensing mechanisms lead to substantial disconnects
in the discovery process, resulting in less well-validated clinical candidates and often limited efficacy in
treating disease.
The proposed research exploits AQT’s PhosphoSens® platform, a kinase assay for purified enzymes that
uses sensor peptides featuring a kinase-recognition sequence and a sulfonamido-oxine fluorophore
conjugated to cysteine (CSox) proximal to the (Ser/Thr/Tyr) phosphorylation site—the synthetic sensor
peptides report on phosphorylation via chelation-enhanced fluorescence (ChEF) in a time-dependent
manner. The PhosphoSens format addresses the limitations of the other kinase assays in a single platform.
This Direct to Phase II proposal will leverage AQT’s PhosphoSens and KinSightTM (a high throughput kinase
profiling platform based on PhosphoSens) for establishing commercial PhosphoSens® Lysate products.
For broad adoption, the new assays must address a range of physiologically and therapeutically critical
kinases, be compatible with complex cell and tissue lysate samples, and be straightforward to apply,
quantitative, rapid, reproducible, and readily run on standard laboratory microplate readers.
Aim 1 focuses on mitogen-activated protein kinases (MAPKs), which play critical roles in cell signaling,
including responses to proliferation and inflammatory signals that drive tumor phenotypes. AQT will
commercialize lysate-compatible sensor peptides for ERK1/2 based on Phase 1 product AQT0491. Sensor
peptides for eight other MAPKs will be developed and validated following Milestone steps 1-3, biochemical
validation, and deployment of sensor peptides to beta test sites for testing with complex samples (e.g., cell
or tissue lysates). AQT will refine sensor peptides as needed before commercial product release.
Aim 2 focuses on additional oncology-centric kinases. Lysate-compatible sensor peptides for PIM1/3 and
GSK3α/ will be commercialized based on Phase 1 products AQT0473 and AQT0157, respectively. AQT
will develop data-driven approaches to prioritize at least six additional protein kinase targets for sensor
peptide development and commercialization following approaches outlined for Aim 1.

Public health relevance
Narrative: Protein kinases are enzymes essential to human health and are frequently associated with many diseases, including cancer. There is an urgent need to accurately measure kinase activity in complex samples, including lysates from human cells and tissues, to improve our understanding of kinase biology and to monitor the effect of new drugs. A new product from AssayQuant Technologies, Inc., designated as PhosphoSens Lysate, combines several innovations to generate selective sensor peptides that addresses this need and fuels new approaches for discovering and validating life-saving medicines to treat human diseases.